Methamphetamine Effect on HIV Persistence

PROJECT SUMMARY
Infection with Human Immunodeficiency virus (HIV)-1 is frequently associated with abuse of psychostimulant
drugs, such as methamphetamine (METH). The interaction of virus and psychostimulant, in particular with regard
to viral persistence, is poorly understood and will be studied here using in vitro and in vivo approaches. We
recently observed that blockade of p38 MAPK and knockdown or deletion of the lncRNA linc02574-201 can
inhibit HIV-1 replication. Therefore, we propose in this application to investigate the mechanism(s) by which
METH apparently promotes HIV-1 infection and the potential contributions of p38 MAPK and lncRNA linc02574-
201. Three Specific Aims are proposed: 1) To investigate how methamphetamine (METH) increases HIV-1
infection of peripheral blood lymphocytes and monocytes/macrophages. This aim will test the hypothesis that
METH exposure affects HIV-1 infection in a concentration- and timing-dependent fashion by promoting the
activity of p38 MAPK and expression of lnRNA linc02574-201. 2) To study how METH interferes with viral
suppression by combined antiretroviral therapy (cART). This aim will investigate how METH exposure affects
viral suppression by cART and the recrudescence of the virus once ARV treatment ceases. This aims will also
assess if inhibition or knockdown of p38 MAPK can prevent the resumption of viral replication after cART, similar
to the knockdown of lncRNA linc02574-201. 3) To assess in a humanized CD34+ HSC-engrafted NSG mouse
model if METH increases the viral reservoir and facilitates the recurrence of HIV during interruption of cART. This
aim will study how METH affects HIV-1 infection, viral suppression by cART and viral recrudescence upon
interruption of cART in an HIV permissive in vivo model, the CD34+ HSC (hematopoietic stem cell)-engrafted
NSG mouse model. The experiments will be performed in vitro with isolated human peripheral blood cells and
cell lines, and in vivo in humanized mice with a CD34+ cell-derived hematopoietic system that provides HIV
permissive human peripheral CD4+ T-lymphocytes and macrophages (MΦ). All three Specific Aims will define
RNA signatures of HIV-1 infected CD4+ T-cells and MΦ in the presence and absence of METH using RNA-
sequencing and will test the proposed mechanism, including increased activity of the stress-related p38 MAPK
and up-regulation of lncRNA linc02574-201. The aims will also monitor factors known to support HIV-1 infection,
such as IRF7, and will test the premise that METH exposure down-regulates a subset of ISGs that include
antiviral factors, such as CCL5, Mx1/2, IFITM2/3 and IRF1 and -3.

Public health relevance
Project Narrative HIV infection and methamphetamine abuse remain substantial public health concerns and despite the availability of antiretrovirals (ARVs) and combined ARV therapy (cART). While cART has shifted the overall picture of HIV-1 disease by providing significant benefits the virus cannot be eliminated and persists. Methamphetamine abuse is known to increase the risk of contracting HIV-1 and the psychostimulant seems to directly affect viral load. The purpose of the proposed research is to better understand the cellular and molecular mechanism underlying the compromising effect of the psychostimulant on cART-dependent optimal viral suppression in order to better counter viral persistence and recrudescence.